Regulation of exon junction complex composition and assembly

ABSTRACT
The exon junction complex (EJC) is deposited by the spliceosome upstream of exon–exon junctions during the
process of pre-mRNA splicing. If an exon–exon is sufficiently downstream of either a normal termination codon
or a premature termination codon (the latter of which can be generated by splicing errors or frameshift or
nonsense mutations), then EJC-dependent nonsense-mediated mRNA decay (NMD) is triggered. NMD destroys
aberrant mRNAs and regulates the normal gene expression of ~5-10% of unmutated mRNAs. I recently
discovered that AKT, a central cell signaling kinase, is a constituent of an alternative EJC containing CASC3
(the AKT EJC) but not UPF2 or RNPS1 (in the canonical UPF2 EJC). AKT functionally replaces UPF2 in UPF2-
independent NMD by activating the key NMD factor UPF1. AKT does so by phosphorylating UPF1; UPF2 does
so by binding UPF1. I found that insulin-mediated activation of AKT signaling increases AKT EJCs at the expense
of UPF2 EJCs, which is the first example of cell-signaling mediated regulation of EJC composition. These
findings are important because AKT signaling and NMD, which converge at the EJC, are both dysregulated in
some cancers, Fragile X syndrome, and type 1 and 2 diabetes. Despite its importance, there are many remaining
uncertainties about how EJCs are formed, including: when and how the commitment to either the AKT EJC or
UPF2 EJC is made; the mechanism by which insulin increases AKT EJC formation; if insulin increases and/or
alters EJC binding at exon−exon junctions; if spliceosomes are involved in alternative EJC formation; the
choreography of steps involved in core EJC formation, presumably on the spliceosome; and how EJCs are
transferred to upstream of exon−exon junctions on newly spliced mRNA, to name a few. In this proposal, I will
start addressing some of these uncertainties while receiving training in concepts and techniques from my
mentoring team so as to continue pursuing these questions in my own lab. In Aim 1 (K99), I will test (i) the
precursor-product relationship between UPF2 EJCs and AKT EJCs (while learning how to generate and use
HEK293T cells engineered for auxin-induced degradation of EJC proteins), (ii) if the insulin-promoted increase
in AKT EJCs and decrease in UPF2 EJCs requires splicing, and (iii) if insulin signaling increases and/or alters
the number of EJC-bound exon–exon junctions (while learning RIP-Seq). In Aim 2 (K99), I will identify and define
any insulin-promoted post-translational modifications (PTMs) on EJC proteins that promote the increase in AKT
EJCs and decrease in UPF2 EJCs (while learning mass spectrometry (MS)-based proteomics and PTM
profiling). In Aim 3 (R00), I will apply my background in mechanistic biochemistry and training in new techniques
to build an independent research program aimed at elucidating yet-undetermined molecular mechanisms in EJC
biology, starting by defining which splicing factors are needed for core EJC assembly, which splicing factors, if
any, are involved in alternative EJC formation, and for the latter, whether PTMs of splicing factors are involved.

Public health relevance
PROJECT NARRATIVE Nonsense mediated mRNA decay (NMD) promotes the normal gene expression of unmutated messenger RNAs (mRNAs) and destroys mutated mRNAs that produce potential disease-causing proteins. The exon junction complex (EJC) is one key determinant of whether an mRNA undergoes NMD and contains the NMD factor UPF2 or the central cell-signaling protein AKT, the latter of which is promoted by insulin. This work will build upon this recent finding by defining the molecular mechanisms involved in this process, which is important because NMD and AKT signaling are both dysregulated in human diseases like Fragile X Syndrome, some cancers, and type 1 and type 2 diabetes.